Towards screening with high-resolution, low-dose, dedicated breast CT

ABSTRACT
Dedicated breast CT is an emerging technology with approximately 20-25 clinical prototypes and clinical systems
worldwide. It does not require physical compression of the breast, can eliminate breast tissue superposition, and
provides 3D images at near-isotropic spatial resolution. Earlier generations of breast CT, while demonstrating
the concept, were suboptimal due to technological limitations and available components. In the prior funding
(R01 CA199044), we focused on the hardware aspects: tested 4 detectors from different vendors, followed by
designing, developing, and testing a dedicated breast CT system that employed an offset-detector geometry to
enable imaging large breasts. This system achieved high resolution and low system noise and was specifically
designed to improve chest-wall coverage and operate at a radiation dose suitable for breast cancer screening.
In the pilot study completed under prior funding (R01 CA199044), the system demonstrated visualization of the
pectoralis muscle in 177/179 (98.9%) breasts (effective diameter at chest wall: 12.82.1 cm); a remarkable
improvement over the 40-78% reported in prior studies, and the mean glandular dose (MGD) was 4.10.9 mGy,
which is similar to that reported for digital mammography (4.15 mGy) in the Digital Mammography Imaging
Screening Trial (DMIST) study. In this competitive renewal, we focus on image reconstruction followed by a
multi-reader, multi-case (MRMC) receiver operating characteristic (ROC) study using prospectively acquired
data to evaluate if dedicated breast CT demonstrates improved performance over the current standard, digital
breast tomosynthesis (DBT) for breast cancer screening. For image reconstruction, we will investigate a total of
5 techniques that were carefully chosen to encompass the current and emerging methods including the standard
Feldkamp-Davis-Kress (FDK) reconstruction, one compressed sensing-based iterative reconstruction that is
well-founded on a rigorous mathematical framework, and three deep learning-based reconstruction techniques
with increasing sophistication, generalizability, and scientific rigor. The deep learning-based methods include a
fully-supervised technique that requires input-reference image pairs and is tuned using physics-based measure,
a self-supervised technique that does not require an independent reference image, and a self-supervised
technique that is based on both the imaging physics and the mathematics of image reconstruction and does not
require independent training data. These methods are not only applicable to dedicated breast CT, but are
adaptable to cone-beam CT, in general, and potentially to the commonly used multi-detector CT. The MRMC
ROC study is based on well-founded image science and is designed with statistical rigor. To our knowledge,
there have been no prior studies comparing the diagnostic accuracy of DBT and breast CT at radiation dose
levels suitable for breast cancer screening. This research addresses this unmet need. This research will not only
provide pivotal data on the imaging performance of breast CT but also advance the state of image reconstruction
that is applicable to the broader field.

Public health relevance
NARRATIVE Dedicated breast CT is a new imaging technique that does not require breast compression, provides fully 3D images, and can eliminate tissue superposition which could reduce unnecessary call-backs for additional imaging and could reduce missed cancers. Building on our prior work on the hardware design and engineering of the breast CT system, in this research, we focus on image reconstruction in breast CT to determine the optimal method, followed by a comparative study with digital breast tomosynthesis (also referred to as 3D mammography) to determine the benefits of dedicated breast CT for translating it to breast cancer screening.